Proteome-wide analysis of AD-associated SNPs

Project Summary
Alzheimer's disease (AD) is a neurodegenerative disorder with no effective cure. Genome-wide association
studies (GWAS) have identified a large number of genetic variants, mostly in the form of single nucleotide
polymorphisms (SNPs), that are associated with AD. Identification of the causative SNPs among the AD-
associated genetic variants will provide important insights into etiology of the disease and therapeutic targets.
Expression quantitative trait loci (eQTLs) studies can identify SNPs that are likely to affect downstream gene
expression. However, this approach cannot provide any information on SNP-binding proteins. Intersecting
GWAS SNPs with transcription factor (TF) binding sites by ChIP-seq is a useful approach to identify functional
SNPs and their interacting TFs but requires a priori knowledge of the relevant TFs. Another option is to identify
differential protein binding to a SNP-carrying DNA fragment using pull down-coupled mass spectrometry;
however, it is difficult to scale up to identify differential binding proteins for a large number of SNPs. In this
proposal, we propose to implement a Proteome-Wide Analysis of disease-associated SNPs (PWAS) study on
non-protein coding regions to identify allele-specific protein-DNA/RNA interactions and alteration of regulatory
activity in AD. This is based on our hypothesis that functional DNA/RNA SNPs likely execute their function via
allele-specific interactions with proteins. We will survey the entire human TF and RNA-binding protein
repertoires with SNP-carrying DNA and RNA probes using a protein array-based approach. This assay is also
extremely high-throughput because >20,000 human proteins can be simultaneously surveyed for each probe.
Identified allele-specific protein-DNA and -RNA interactions will be prioritized using a series of bioinformatics
analyses and validated using human cells differentiated from induced pluripotent stem cells. To achieve our
goals, we propose four aims. Aim 1: Determine DNA allele-specific SNP-TF interactome. We will perform
protein-DNA interaction assay with 75 AD-associated SNPs validated by gel-shift assays. Aim 2: Identify RNA
allele-specific SNP-protein interactome. We will focus on 75 SNPs located in 5'-UTR, 3'-UTR and intronic
regions, which are likely to affect RNA splicing, mRNA stability, and protein translation. Aim 3: Assess the
biological consequences of prioritized allele-specific interactions in AD relevant specific cell types. We will
integrate the protein-DNA/RNA interactions with existing genomic datasets to prioritize a subset of allele-
specific protein-DNA/RNA interactions for validation in human cell populations. Aim 4: Construct a PWAS
browser for human diseases. We will develop a user-friendly PWAS browser to distribute the allele-specific
protein-DNA/RNA interactions that are relevant to human diseases. The success of this project is expected to
establish a powerful platform and provide a rich resource to rapidly identify functional SNPs and provide crucial
biological insights into the molecular mechanisms underlying AD.

Public health relevance
NARRATIVE Successful identification of genetic risk factors associated with human diseases has thus far outpaced the investigations into the biological consequences of these genetic variants, most of which have focused on individual genes or known targets. This project aims to take an unbiased approach to survey the interactions of over 100 genetic variants associated with Alzheimer's Disease with the whole human proteome, which may lead to novel mechanistic insight and provide a new platform to study genetic risk.